Development of GPR139 antagonists for the treatment of pain

PROJECT SUMMARY
Opioid analgesics are the most effective drugs to treat acute pain; however, chronic use leads to tolerance,
dependance, and addiction. Misuse of prescription opioid drugs is the key reason for the current opioid
epidemic in the US. The analgesic effects of opioids are primarily mediated through activation of the µ-opioid
receptor (MOR), thus modulation of MOR signaling represents a promising strategy for pain management.
GPR139 is extensively co-expressed with the MOR in the medial habenula and locus coeruleus, brain regions
implicated in drug dependence and opioid analgesia. Multiple lines of evidence from cell-based and GPR139
knockout mice behavioral studies suggest that GPR139 negatively regulates MOR signaling and analgesic
effects. Thus, we hypothesize that a GPR139 antagonist may enhance the analgesic efficacy of opioid
medicines, thus necessitating a lower dose of opioids and thereby increasing opioid safety.
Despite the premise of GPR139 as a novel target for the treatment of pain, investigation of GPR139
antagonism in behavioral responses to opioids (e.g., morphine) has been hampered by the lack of a suitable
antagonist probe for in vivo studies. To date, our group has made significant progress in this regard. We have
developed the GPR139 binding and functional assays to assess the ligand-receptor interaction and GPR139
activity. We have also carried out a preliminary structure-activity relationship (SAR) study of a known GPR139
antagonist scaffold, which led to the discovery of a promising lead JD-1 with improved potency,
physicochemical properties, and metabolic stability. In this R21 application, we propose to develop a suitable
antagonist probe and evaluate its effects in morphine analgesia through three iterative specific aims. In Aim 1,
we will optimize potency, receptor selectivity, and drug-like properties of GPR139 antagonists using medicinal
chemistry. In Aim 2, we will characterize compounds using a GPR139 calcium assay and a radioligand binding
assay. Selected compounds will be assessed for receptor selectivity against GPR142, and further evaluated in
a target profiling screen. Potent and selective compounds will then be characterized using a battery of ADME
and pharmacokinetic assays. In Aim 3, we will test one best compound, developed in Aims 1 and 2, in thermal
pain models (tail immersion and hot plate) and in morphine-induced conditioned place preference (CPP) to
determine whether the GPR139 antagonist can facilitate morphine analgesia and at effective doses without
producing the side effect on morphine reward. Overall, completion of this project will produce in vivo antagonist
probes and provide the first direct evidence to validate the GPR139 antagonist as an adjuvant to morphine for
the treatment of pain.

Public health relevance
PROJECT NARRATIVE This R21 project aims to develop a potent, metabolically stable, and brain-penetrant GPR139 antagonist and test its effects on morphine analgesia and reward. Studies have shown that blocking GPR139 results in increased morphine analgesia in thermal and mechanical pain paradigms with no signs of decreased health effects and a reduction in morphine dose to achieve overall effective pain management. Ultimately, this research program could lead to novel therapeutic agents as adjuvants to opioid analgesics for pain management.